Neural Pathways for Metabolic Control of Ingestion

DESCRIPTION (provided by applicant): Maintaining an adequate supply of glucose, the brain's essential metabolic fuel, requires receptor cells that monitor brain glucose availability and engage neural circuitry capable of eliciting endocrine, autonomic and behavioral responses to restore glucose when levels fall. Our work has revealed that hindbrain catecholamine (NE/E) neurons are required for elicitation of a number of key responses to glucose deficit, including stimulation of feeding, corticosterone (CORT) and adrenal medullary secretion and suppression of reproductive responses. Understanding hindbrain glucoregulatory circuitry has been a continuing effort in our lab and is the focus of this application. Two major gaps in our knowledge of this hindbrain system will be addressed by this proposal. First, we do not understand the circuitry by which rostrally-projecting NE/E neurons mediate feeding and corticosterone responses to glucose deficit ("glucoprivation"). Second, although we've shown that NE/E neurons are required for elicitation and coordination of glucoregulatory responses during glucose deficit, we do not know whether E/NE neurons are themselves glucose- sensors. The proposed work will determine the contribution of NE/E innervation of the ventral tegmental (VTA) dopamine (DA) system to elicitation of appetitive feeding responses by systemic glucoprivation and determine whether this VTA innervation arises from the same NE/E neurons mediating the CORT response to glucoprivation. Experiments will utilize the retrogradely transported targeted immunotoxin, anti-dopamine beta hydroxylase saporin (DSAP) to selectively lesion NE/E neurons innervating the VTA without damaging the VTA DA neurons. The proposed work will also use gene silencing to further delineate the specific hindbrain NE/E cell groups that mediate glucoprivation-induced feeding and/or corticosterone secretion. Finally, the proposed work will examine the contribution of 5'adenosine monophosphate-activated protein kinase (AMPK), a cellular energy sensor and regulator, to the function of hindbrain NE/E neurons during glucose deficit and the possibility that these neurons are glucose sensors. Our long-term goal is to determine the potential of hindbrain NE/E neurons to serve as glucose sensors and to establish the roles of their afferent inputs and efferent outputs in the overall physiological response to glucose deficit. We believe that our work will have a significant impact on human health. Unraveling glucoregulatory circuits will enable assessment of their involvement in metabolic disorders such as Type 2 diabetes, obesity and the potentially lethal complication of insulin therapy in diabetics (known as Hypoglycemia Associated Autonomic Failure, or HAAF), in which severe reductions in glucose availability fail to trigger life-saving glucoregulatory responses. PUBLIC HEALTH RELEVANCE: Glucose is the brain's essential metabolic fuel. This proposal is focused on mechanisms by which the brain protects its glucose supply and extends our previous work demonstrating the required participation of hindbrain catecholamine neurons in protective and restorative responses to glucose deficit. The proposed work will delineate the catecholamine projections that mediate two critical responses to glucose deficit, feeding and corticosterone secretion, and will examine the potential role of hindbrain catecholamine neurons as glucose sensors. Results will provide new insights into the ways in which hindbrain glucoregulatory mechanisms contribute to or are altered by obesity, diabetes and other metabolic diseases.

Public health relevance
Glucose is the brain's essential metabolic fuel. This proposal is focused on mechanisms by which the brain protects its glucose supply and extends our previous work demonstrating the required participation of hindbrain catecholamine neurons in protective and restorative responses to glucose deficit. The proposed work will delineate the catecholamine projections that mediate two critical responses to glucose deficit, feeding and corticosterone secretion, and will examine the potential role of hindbrain catecholamine neurons as glucose sensors. Results will provide new insights into the ways in which hindbrain glucoregulatory mechanisms contribute to or are altered by obesity, diabetes and other metabolic diseases.